Innovative Sorbents for Stabilizing Per- and Polyfluoroalky Substances (PFAS) in Soil Contaminated by Aqueous Film-forming Foam (AFFF)

Project Summary/Abstract: Per- and polyfluoroalkyl substances (PFAS) are a group of chemicals
consisting of thousands of synthetic organic compounds in which the hydrogen atoms bound to the carbon
backbones are fully or partially substituted with fluorine. Due to their widespread use, PFAS are detected
ubiquitously. Owing to the nature of PFAS being persistent, bioaccumulative, and toxic, cleaning up PFAS
contaminated environments has been an urgent task globally. While numerous technologies, for example
chemical, biological, thermochemical, sonochemical, etc. have been studied and used for removing PFAS
from contaminated environments, none of these are without any drawbacks. In many cases, the intentional
remediation processes that are often cost- and/or energy intensive, lead to generation of un-desired
degradation products and/or secondary contamination. To avoid these potential negative effects,
stabilization that seeks to retain PFAS in its original environment for long-term has gained momentum in
recent years. To promote the formation of bound residues (BR) between PFAS and soil, different sorbents
have demonstrated different capabilities. Even the best sorbent on the market, however, is not able to bind
PFAS stable enough to withstand extraction by basic methanol. Additionally, sorption of short-chain PFAS
and precursors has been a huge challenge for all sorts of sorbents. We propose here to test our newly
synthesized sorbents with respect to forming stable BR in the soil-sorbent-plant systems. Our preliminary
studies have shown that the three top-performing sorbents have higher sorption capacity and faster rate
than those commercially available. In this Phase I proposal, we plan to understand the leachability and
bioavailability of three types of PFAS in the near real-world mesocosms. Besides mass balance of the PFAS,
correlations between BR and other parameters, such as soil total organic carbon content, PFAS chain length
and functional group, precursor transformation, and growth of and uptake of PFAS by alfalfa will be
established. In addition to having a deep understanding of PFAS transformation, distribution, and
stabilization in the target systems, we propose to elucidate the BR structure and dynamics at the atomic
level. This will benefit from a combination of chemical analysis and 19F solid-state NMR. Insights gained
from these deep studies will enable us to fully understand the mechanisms controlling binding between
PFAS, soil, and sorbent; pinpoint the deciding factors and parameters contributing to the formation of the
strongest possible BR; and guide us in designing and engineering the next generation sorbents. Success of
this project will lead to a cost-effective, scalable, and green approach for remediating sites contaminated by
PFAS, reveal the binding mechanisms underlying BR formation, and result in novel sorbents for not only
stabilizing PFAS in soil, but also for removing PFAS from contaminated water and beyond.

Public health relevance
Project Narrative Stabilizing PFAS in its original environment has become a highly feasible approach for preventing further spread or migration of PFAS to surrounding locations, but green, innovative, and suitable sorbents that are able to form stable bound residues (BR) between PFAS and soil are lacking. We propose here to test our newly synthesized sorbents with respect to their effect on stabilizing three types of PFAS in the soil-sorbent- plant systems and elucidate the mechanisms responsible for the formation of stable BR. Success of this project will lead to a cost-effective, scalable, and green approach for remediating sites contaminated by PFAS, reveal insights for designing and engineering the next-generation sorbents, and result in novel sorption materials for not only stabilizing PFAS in soil, but also for removing PFAS from contaminated water and beyond.